mRNA-based chimeric membrane protein vaccination strategies directed at the MPER

SUMMARY – PROJECT 1
Neutralizing antibodies are a major component of vaccine-induced protective immunity. However, induction of
broadly neutralizing antibody (bnAb) against the trimeric HIV-1 envelope (Env) spike protein gp160 continues to
be a challenging goal. An effective vaccine must address the remarkable antigenic variability of gp160, its
extensive glycan shield and/or conformational masking of conserved neutralizing target epitopes. Among bnAb
targets, the membrane proximal external region (MPER) of gp41, the Env subunit critical for virus fusion, is
attractive given its linear and highly conserved sequence as validated by the neutralization breadth of 4E10,
10E8 and DH511 bnAbs. Nonetheless, the poorly immunogenic nature of the MPER during the natural course of
infection and the lack of neutralizing activities elicited by structure-based MPER immunogens demand an
alternative immunogen design approach. The accessibility of the MPER is limited, being shielded by gp160
trimer ectodomain from above and the viral membrane from below. Furthermore, our recent MPER/liposome
results suggest that the unrestricted approach angle afforded to the B cell receptor with current vaccine
formulation is problematic, inducing a majority of polyclonal Abs as well as recombinant monoclonal Abs that lack
Env reactivity. Therefore, MPER immunogens must mimic spatial occlusion while enforcing limited Ab
accessibility to the MPER in a manner analogous to that imposed by the quaternary structural configuration of
gp160 on the virion surface. In that regard, our recent analyses of the trimeric HIV-1 Env structure and molecular
dynamics (MD) in nanodiscs provide compelling data for novel vaccine design considerations. With advanced
messenger RNA lipid nanoparticle (mRNA-LNP) vaccine technology, Project 1 proposes to create novel
mRNA-based immunogens that encode trimeric spike-MPER-TM (the MPER and adjacent transmembrane
segment) chimeras. Therein the Env ectodomain is replaced by structurally suitable host self-proteins, focusing
Ab responses solely against the conjoint membrane-arrayed viral MPER-TM epitopes. In Aim1, a pipeline
involving automated computational searches of the PDB followed by MD and single-particle cryo-electron
microscopy (cryoEM) structures in collaboration with Project 2 will generate multiple candidate immunogens.
Optimization and further modifications of mRNA-LNP vaccines will be tested by 1) in vitro expression, 2)
antigenicity and antigen presentation, and 3) in vivo immunogenicity studies. The latter use knock-in (KI) mice
harboring introduced human Ig D3-3 and JH6 gene segments for long CDRH3 generation. In Aim 2, genetic,
biochemical and functional characteristics of vaccine-elicited Abs at the single B cell level will be determined and
compared with human bnAbs analyzed structurally in Project 2. The integrated analyses will offer iterative
immunogen improvements to enhance the quantity and quality of anti-MPER Abs. In Aim 3, strategies will be
developed to prime germline bnAb precursors and then selectively expand memory B cells by heterologous
boosting to generate long-lived plasma cells in bone marrow producing high titer bnAbs in plasma.